Understanding and Engineering Chemically Activated Ubiquitin Ligases

Project Summary/Abstract
The objectives of my research program are to understand and engineer protein degradation by the
ubiquitin-proteasome system—a critical signaling mechanisms that all animals, plants, and fungi use
to perceive and adapt to their environment. The ubiquitin-proteasome system acts like the recycling
system of the cell, where specific proteins are marked for recycling by ubiquitin and are cut into
peptides by the proteasome to be further broken down and made into new proteins. The ability of the
ubiquitin-proteasome pathway to remodel a cell’s proteome in a rapid and specific way has perhaps
led to its ubiquity throughout the evolution of eukaryotes. The strong conservation of ubiquitin in
eukaryotes also makes it a prime candidate for engineering control systems in biology. The ubiquitin-
proteasome machinery in humans is frequently implicated in cancers, neurodegenerative diseases,
and metabolic disorders among other diseases, due to it is involvement in cell cycle regulation,
vascular development, and inflammation, among other critical processes. By improving our
understanding of how the ubiquitin-proteasome pathway functions or fails to function, we may
uncover new ways to treat or prevent human disease. The ubiquitin-proteasome pathway plays
perhaps an even more central role in plants where it is involved in nearly all known plant hormone
signaling pathways to coordinate their growth and respond to changes in their environment, including
stresses such as pests and pathogens. These chemical hormones activate ubiquitin ligases which
trigger degradation of repressive transcription factors leading to activation of hormone-responsive
gene transcription. Interestingly, animals and microbes also perceive plant hormones which have
wide ranging effects on their physiology. Animals and microbes also produce plant hormones or
similar molecules to aberrantly activate ubiquitin-proteasome signaling and manipulate plants for their
benefit. Our research aims to understand the molecular mechanism of how information is transferred
through these ubiquitin-proteasome signaling pathways and how these hormone-signaling and
biosynthesis pathways have coevolved in plants and other eukaryotes. To do this we will use a deep
mutational scanning approach enabled by a massively parallel functional assays using a biosensor
we recently developed. In parallel, we aim to re-engineer these chemically activated ubiquitin ligases
to detect related and potentially novel chemical compounds and to act as rapid metabolic controllers.
These molecular tools will improve our ability to control and engineer biological systems and
sustainably biomanufacture these plant hormones and related chemicals, including important
agricultural and industrial chemicals, nutritional supplements, and pharmaceuticals.

Public health relevance
Project Narrative Ubiquitin ligases are enzymes that attach a protein signal called ubiquitin to specific proteins, which often results in the recycling of these proteins by the cell. Ubiquitin ligases are critical to the survival of all animals, plants, and fungi, and disruption of their function results in numerous diseases in humans including most cancers and neurodegenerative diseases. We study the molecular function of ubiquitin ligases to gain new insights into how they function and use them as a scaffold to engineer biosensors to study disease, engineer biological systems, and improve sustainable manufacturing of foods, fuels, pharmaceuticals, and other chemicals.